Mouse Genetics Core

Abstract Mouse models provide highly tractable models with which to assess, identify and mechanistically characterize the role of genetic variants on infectious disease responses. The Mouse Genetics Core has been at the forefront of designing experimental crosses, sequence datasets and other mouse resources with which to investigate and perturb polymorphic immune networks. Following the identification of polymorphic host genome regions, aberrant mouse lines, and discordant immune spreads or candidate genes and pathways from human studies (in close collaboration with the Projects and the Systems Genetics and Bioinformatics core), we will generate a variety of mouse experimental models for the Projects to further assess, identify and characterize these processes. These models will include F1 panels contrasting variant disease alleles, F2 mapping populations, and mouse strains with modified candidate genes. Concurrently, designing the appropriate experiments for the study of viral disease requires an understanding of the underlying immune composition of individuals. Therefore, the Core will identify and further characterize genetic variants impacting basal immune responses; both intra-cellular as well as at the whole-organism level. These data will be provided to the projects to enhance their assessment of antiviral and/or perturbed response.

Public health relevance
Project Narrative Genetic variants can impact human infectious disease responses, however it is often unclear which variants affect infection or how they do so. This core will generate mouse models and crosses which can be used to identify genes with variants impacting viral infection outcome, and also understand the mechanisms through which this different infection outcome is achieved.